The role of rRNA transcription and ribosome biogenesis in neural crest progenitors and stem cells during embryonic and postnatal craniofacial development

ABSTRACT
Craniofacial anomalies are the most common malformations present at birth and comprise up to 1/3 of all
congenital defects. Most of the craniofacial cartilage, bone and connective tissue are derived from neural crest
cells (NCC), a migratory stem and progenitor cell population born during early embryogenesis. The majority of
craniofacial disorders are therefore thought to be a result of disruptions in NCC development3. In order to improve
the prognosis for individuals affected with craniofacial anomalies, and to develop potential preventative
therapies, there is a critical need for a deeper understanding of the fundamental mechanisms that govern the
formation, migration and differentiation of NCCs during craniofacial morphogenesis4. Recent work in our lab
demonstrated that RNA Polymerase I (Pol I)-mediated ribosomal RNA (rRNA) transcription, which is the rate
limiting step in ribosome biogenesis, is elevated in NCCs compared to other cell types5, 6. This is necessary to
meet NCC’s higher protein translational requirements and underpins their high rate of proliferation, epithelial to
mesenchymal transformation, and metabolically expensive migration properties5. In support of this idea, NCC-
specific disruption of Pol I function leads to increased NCC death and craniofacial anomalies characteristic of
congenital craniofacial disorders such as Treacher Collins syndrome and Acrofacial Dysostosis-Cincinnati type5,
7, 8. Additionally, evidence from other studies supports elevated requirements for ribosomes and translational
capacity in order for stem cells to acquire new fates, suggesting that ribosome biogenesis also plays a critical
role during the differentiation stage of NCC development. Based on our previous findings I hypothesize that
increased rRNA transcription and ribosome biogenesis are essential for both NCC-derived progenitor and stem
cell maintenance and differentiation during embryonic and also juvenile phases of craniofacial development. To
test this hypothesis, I will genetically delete Polr1a, the catalytic core of Pol I, in tamoxifen-inducible global and
tissue-specific mouse lines. Then through phenotypic and cellular analyses, in combination with transcriptomic
and proteomic approaches, I will define the mechanisms driving the anatomical anomalies that result from
disruptions in Pol I function. My results will provide new knowledge on the roles of rRNA transcription and
ribosome biogenesis in craniofacial progenitor and stem cell populations during embryonic and postnatal
development. The findings can potentially uncover new therapies for preventing or ameliorating ribosomopathies,
and improve clinical outcomes for craniofacial patients, especially when it comes to corrective surgeries, through
improved postnatal growth predictions.

Public health relevance
PROJECT NARRATIVE Developmental anomalies affecting the head and face are among the most common congenital defects, and affected individuals typically undergo extensive surgical, dental, speech and other therapies, spanning many years, which imposes a significant psychosocial and financial burden. This project, through the generation and analysis of new mouse models to study craniofacial disorders, will lead to novel discoveries in the fundamental genetic, cellular and biochemical mechanisms that are essential for embryonic and juvenile growth and development. Results have the potential to guide new therapies and improve the clinical management of patients.